DRUVA INSYNC ENTERPRISE STORAGE SOFTWARE SUPPORT AND MAINTENANCE

The purpose of this acquisition is to procure Druva software. Druva is a cloud based endpoint backup system that allows unlimited backup capacity for all licensed users. It allows for easy end user management of their data as well as enterprise policies to protect the overall endpoint. Druva is a fedramp authorized software as a service (SaaS) allowing federal agencies to safely and securely protect desktop and laptops to their cloud service, for the NHLBI’s Information Technology and Application Center (ITAC) in support of NHLBI mission needs